Regulation of ROR-gt in colonic inflammation

ABSTRACT Dysregulated ROR-γt-mediated IL-17 expression is strongly associated with chronic inflammation. However, the molecular mechanisms by which ROR-γt functions and how its stability is regulated remain elusive. Our preliminary studies suggest that under steady-state conditions in the gut, ROR-γt is sumoylated in Th17 cells by UBC9 (SUMO-E2 ligase) and TRIM55 (SUMO-E3 ligase). Additionally, we found that under steady-state conditions, a novel NCOA6-HDAC2 repressor complex binds to ROR-γt. Upon T cell receptor stimulation, de- sumoylation removes this repressor complex, resulting in IL-17 transcription. To prevent a prolonged Th17 response following stimulation, ROR-γt is phosphorylated by the kinase Pak2, which promotes Itch-mediated ROR-γt ubiquitination and subsequent degradation. Based on these findings we hypothesize that that ubiquitination and sumoylation of ROR-γt are critical molecular events that regulate Th17 responses and that can be targeted therapeutically. In AIM 1, we will determine the mechanism by which sumoylation of ROR-γt represses IL-17 transcription. By using newly generated CD4 T cell-specific TRIM55-/- mice, we will investigate the mechanism by which the NCOA6/HDAC2 complex utilizes histone deacetylation to repress IL-17 expression. In AIM 2, we will determine the mechanism by which phosphorylation promotes Itch-mediated ROR-γt ubiquitination. Using Pak2-/- mice, we will investigate how the phosphorylation-dependent conformational change of ROR-γt promotes its degradation. In AIM 3, we will target the Itch-ROR-γt-IL-17 pathway to inhibit excessive inflammation. We will test the therapeutic potential of a small-molecule Itch activator to inhibit colonic inflammation. Completion of these studies will lead to a clear understanding of the molecular mechanisms by which ROR-γt function and its stability are regulated to prevent chronic inflammation. This knowledge should lead to improved therapeutic strategies to target the ROR-γt-IL-17 pathway in human inflammatory diseases.

Public health relevance
NARRATIVE Abnormal expression of the cytokine IL-17 can be controlled by ROR-γt and is strongly associated with inflammatory disorders. We propose to investigate the mechanism by which modifications of the ROR-γt protein prevent excessive IL-17 expression and as a result prevent chronic inflammation. Completion of this project should lead to novel treatment strategies for IL-17-driven inflammatory diseases.